Optimization and Implementation Trial of a User-Centered Emergency Care Planning Tool for Infants with Medical Complexity

PROJECT SUMMARY/ABSTRACT
Dr. Pulcini proposes a five-year research training program to support his development into an independent
physician-scientist dedicated to improving emergency care of children with medical complexity, which account
for approximately 20% of all pediatric emergency department (ED) visits and 33% of all healthcare spending
among children. Dr. Pulcini’s project goal is to optimize and implement a user-centered emergency care
planning tool to improve outcomes for infants with medical complexity (notably those in rural areas), a
particularly vulnerable subset of this patient population. Under the first aim of the proposal, Dr. Pulcini will
optimize an existing emergency care planning tool that, despite advocacy for children with medical complexity
by two professional societies, has been poorly implemented to date. Dr. Pulcini will optimize the emergency
care planning tool for infants with medical complexity through iterative semi-structured and targeted interviews
and surveys of tool users: providers, local interdisciplinary collaborators, and families. Under the second aim,
Dr. Pulcini will design and conduct a randomized feasibility trial of the user-centered emergency care planning
tool’s implementation, measuring resultant emergency health care outcomes. As part of the trial
implementation process, Dr. Pulcini will monitor barriers to implementation, as well as measure key emergency
health service research measures with plans for cost-effectiveness analysis for a full-scale future randomized
controlled trial to be submitted as an R01.
Dr. Pulcini’s training program is focused on dissemination and implementation (D&I) science, supplemented
with training in clinical trials and health services measure development. The training in D&I science builds upon
Dr. Pulcini’s previous training in pediatric emergency medicine and maternal and child health. Dr. Pulcini’s
research will be supported by an accomplished group of mentors with expertise in D&I science, clinical trials,
pediatric emergency medicine and health services research. His mentors are dedicated to ensuring his career
development into an independent clinical investigator through successful conduct of the proposed project and
training plan. By providing Dr. Pulcini with the skills and mentored experience necessary to complete this
proposal, he will be well positioned to succeed as an independent scientist and significantly improve the
emergency care of children with medical complexity.

Public health relevance
PROJECT NARRATIVE Infants with medical complexity are a medically vulnerable population with high emergency department and inpatient resource use, disparities in care (notably among rural populations), and significant adverse emergency health outcomes. Through the proposed training and research plan, the PI will optimize and implement an advanced emergency care planning tool for infants with medical complexity through a user- centered dissemination and implementation science approach.